Skeletal Microstructure - Racial Differences and Genetic Contributors

Osteoporosis is characterized by low bone mineral density (BMD) and microstructural deterioration. While
BMD has high heritability, genetic testing for variants associated with osteoporosis or fracture plays no role in
the clinical assessment of bone health. Most of the genetic variance of BMD has yet to be accounted for.
Attempts to address this issue have been impeded by the genetic approaches utilized and the skeletal
outcomes assessed. Genome-wide association studies (GWASs) cannot identify rare variants. Such rare
variants, which can be identified by whole exome sequencing (WES), often have large functionally important
effects. Moreover, rare variants are relevant to common, polygenic conditions. Some of the “missing
heritability” of osteoporosis is likely due to unidentified rare variants. Further most GWASs have assessed
genetic associations with “bone mineral density” (BMD) or “fracture”, both outcomes of heterogeneous
pathogenic processes. To overcome these limitations, we will use WES to assess specific skeletal traits, such
as microstructure or matrix properties, that predispose to or protect from fracture. Such traits are less
genetically heterogeneous and more amenable to genetic analysis. Thus, tools other than DXA, such as high
resolution peripheral quantitative computed tomography (HRpQCT) and impact microindentation (IMI) that can
measure specific skeletal elements contributing to fracture are useful to identify osteoporosis genes. With
HRpQCT, we have made progress by identifying in minorities, novel imaging-based bone phenotypes
conferring greater bone strength despite lower or similar BMD by DXA. Using WES, we have begun to study
the genetics of these racial differences. Our data indicate this is a powerful approach to identify genetic
contributors to microstructure. The goal of this project is to phenotype a large, population-based, multi-ethnic
cohort with existing WES data using HRpQCT and IMI in order identify genes regulating bone microstructure
and matrix properties. In doing so, we can assess how racial differences in causal variant allele frequencies
dictate racial differences in these traits. Lastly, we will assess if identified variants are associated with
fractures. A major strength of this study is the availability of WES data, which in contrast to GWAS, allows for
the identification of both common and rare coding variants. Our gene-based statistical approach is a powerful
method, making this approach feasible with our sample size. These methods have been used to identify new
disease-causing genes (not found with GWAS) that regulate lipids, height, infectious susceptibility, epilepsy
and other conditions. It has only begun to be explored in osteoporosis, but offers a way to identify novel genes
with important biological effects not detected by GWAS. The overarching hypothesis is that skeletal
microstructure and matrix properties are under genetic regulation and genes underlying them can be identified
using WES. Ultimately, identification of such genes may enhance understanding of skeletal regulators, which
may lead to the development of genetic tests and identification of new drug targets for osteoporosis.

Public health relevance
Osteoporosis is a major and growing public health problem, but the exact pathogenetic mechanisms at play in most individuals with osteoporosis are unclear. As such, the available diagnostic tests and treatments are limited in precision and efficacy. The goal of this grant is to identify genes regulating skeletal microstructure and matrix properties in a large multi-ethnic cohort with existing whole exome data, which may ultimately lead to the development of new tests for the predisposition to osteoporosis as well as new drug targets for the disorder.